EVALUATION OF THE SAFETY OF GLUTAMINE ADDED TO TPN &GIVEN TO NORMAL VOLUNTEERS

The purpose of this study was to evaluate the potential toxicity of the amino acid glutamine when combined with other amino acids and parenteral nutrients and infused intravenously over a five day period into normal individuals.